Tissue and Pathology/Immunology Core

Project Summary/Abstract
The overall goal of this Tissue/Pathology/Immunology Core (Core C) is to acquire, preserve, and distribute
clinically-­annotated, high-­quality human biospecimens related to cervical cancer and HPV disease, and to
provide pathologic and immunologic expertise, support, and in situ analyses for tissue-­based analyses for
investigators in the Cervical Cancer SPORE at the Johns Hopkins University, the University of Alabama at
Birmingham, and the University of Colorado at Boulder, as well as external collaborators. Core C has been in
existence since 1998, and has expanded with the support of the Cervical Cancer SPORE. To date, we have
banked blood, cytologic and tissue samples from 4299 subjects and supported 6 clinical trials. All human tissues
and biologic fluids are harvested and banked in accordance with the National Cancer Institute’s Best Practice
Guidelines for Biorepositories. Core C personnel have been expanded to strengthen expert pathologic and
immunologic consultation to investigators, including guidance for quantitative digital image analyses of
multiparameter molecular studies of tissues, microdissection, preparation of tissue microrarrays, HPV
genotyping, HPV seroepidemiology and HPV Antigen Functional Expansion of Specific T cells (FEST) via TCR
Vβ clonotype sequencing and quantitation. Collection of tissue, cytologic and blood specimens is supervised by
gynecologic pathologists and clinical colleagues in gynecology. Clinical information for subjects enrolled in our
clinical protocols is entered into a password-­protected web-­based tracking system. This internal web-­based
system follows the recommendations of the National Research Council, and includes user authentication,
encryption, audit trails, and disaster recovery. A review mechanism is in place for prioritization of distribution of
requested resources to investigators within and external to the Johns Hopkins Cervical Cancer SPORE.
Biosamples have been shared with collaborators at academic institutions across the country. This shared
resource is pivotal to the success of all four HPV vaccine-­based SPORE projects and will support all four HPV
vaccine-­based SPORE projects external collaborators, as well as the Developmental Research Program
(DEP) and Career Enhancement Program (CEP) awardees, and external collaborators. Core C is led by Drs.
Anna Yemelyanova, M.D. (UAB), Lawrence Lamb, Ph.D. (UAB), Raphael Viscidi, M.D. (JHU), and Russell Vang,
M.D. (JHU). Co-­Investigators that support Core C include Drs. Kellie Smith, Ph.D. (JHU), Sailesh Pillai, Ph.D.
(UAB), Deyin Xing, M.D., Ph.D. (JHU), and Robert Anders, M.D., Ph.D. (JHU).

Public health relevance
Project Narrative The Tissue/Pathology/Immunology Core (Core C) will acquire, process, preserve, and distribute clinically- annotated, high- quality human biospecimens harvested from studies related to cervical cancer and HPV disease, and provide pathologic interpretation and immunologic expertise, support for tissue- based molecular analyses for investigators in the Cervical Cancer SPORE at the Johns Hopkins University, the University of Alabama at Birmingham, and the University of Colorado at Boulder, as well as external collaborators.